Enhancing and Archiving Genomic Data of the PSID Child Development Supplement

Project Summary
The Panel Study of Income Dynamics (PSID) is a longitudinal survey of a nationally representative sample of
U.S. families that began in 1968. Together with the PSID Child Development Supplement (CDS) and the PSID
Transition into Adulthood Supplement (TAS), the overall PSID data archive has been instrumental in advancing
social, behavioral, and economic research within a life course and intergenerational perspective. A growing
body of evidence suggests that genetic factors play a key role in health, behavioral, and socioeconomic out-
comes in childhood, over the life course, and across generations. However, such information is currently ab-
sent from the PSID data archive. In the 2014 wave of CDS (CDS-14), 2,513 saliva samples from children and
their primary caregivers (typically a parent) were collected and subsequently sequenced to obtain genome-
wide genetic data. These genomic data provide unprecedented new opportunities to study a variety of social-
genetic effects on childhood and life course outcomes that capitalize on the existing strengths of PSID. How-
ever, with an extremely large dataset that contains >37 million variables and occupies more than 3 TB disk
space, genomic data pose insurmountable challenges to all but the most sophisticated analysts. We will ad-
dress these challenges by undertaking important enhancements that will help researchers to use genomic data
efficiently and effectively with minimal start-up time. The specific aims of this project are to: 1) develop im-
portant secondary data that are essential for genetic analyses, including a genetic relatedness matrix, popula-
tion-level and ancestry-specific genetic principal components, and imputed genotypes for the unmeasured non-
primary caregiver parent of each child; 2) produce additional genomic data products, including polygenic
scores and candidate SNP files for a variety of social/behavioral traits and health outcomes; 3) prepare com-
prehensive documentation of the CDS-14 genomic data and derived measures and publicize their availability to
current and prospective data users. The enhancements will allow researchers to efficiently and effectively in-
corporate genomic data when addressing crucial scientific questions about how genetic propensity and the so-
cial environment intervene to shape health, behavior, and well-being in childhood, over the life course, and
across generations. This project will also lead to the first formal dissemination of PSID genomic data and pro-
vide an important foundation for future work as we continue to expand and enhance genomic data in PSID and
CDS.

Public health relevance
Project Narrative This project will enhance basic genomic data from the 2014 wave of the Child Development Supplement to the Panel Study of Income Dynamics in a number of important ways. It will create new genomic measures, make them available to the research community free of charge, and promote their use through comprehensive documentation and outreach efforts. This project will allow researchers to use these new genomic measures to answer crucial scientific questions about how genetic propensity and social environment intervene to shape health, behavior, and well-being.